SRI Meeting: Training and Development in the Reproductive Sciences

PROJECT SUMMARY
The annual Society for Reproductive Investigation (SRI) meeting brings together both clinical and basic
scientists from around the world to discuss research related to women's health and reproductive science.
The highly successful annual SRI meeting has had an average attendance of 1062 investigators over the
last five years and has brought together established senior and junior investigators to report and discuss
their findings in an atmosphere conducive to frank yet amicable exchange. This application seeks funding
to cover travel costs to allow seven trainees and new investigators to attend SRI annual meetings. This
proposal also seeks funding to support the travel costs of a senior US-based investigator who will present
an invited Distinguished Presidential lecture at the meeting. Meetings are scheduled in March of each
year in Brisbane, Australia (2023) and Vancouver, British Columbia, Canada (2024). The four-day
meeting includes two or three Distinguished Presidential Lectures, oral and poster presentations, 12 mini-
symposia, a new investigator plenary, career development and diversity forums, and networking events.
The 70th Annual SRI Scientific Meeting will be held in Brisbane, Australia, March 21-25. The SRI will
continue its efforts to ensure adequate representation of new investigators, underrepresented minorities
and women as attendees, speakers, and session chairs at each annual meeting.

Public health relevance
PROJECT NARRATIVE The Society for Reproductive Investigation (SRI) meeting serves to bring together scientists and clinicians, established and early career investigators from around the world, to report and discuss their findings in an atmosphere conducive to productive scientific exchange. This application seeks funding to cover travel costs for seven trainees and early stage investigators to attend the annual SRI meeting and for an established investigator to attend the meeting where he/she will present an invited Distinguished Presidential plenary lecture.